Genomic and exposomic factors in the cause and rise of autism

ABSTRACT
This collaboration between the Children’s Hospital of Philadelphia (CHOP) and the University of
Pennsylvania (Penn) focuses exactly on the key priorities set out for Autism Data Science Initiative: 1) to
identify genetic and environmental factors that lead to an autism diagnosis and 2) determine how these
factors have either contributed to or are reflected in the rising prevalence. Most of the existing research
on environmental contributions to ASD focuses on isolated exposures, neglecting the systemic nature of
real-world environmental interactions. This gap limits the development of actionable risk models for early
diagnosis and personalized intervention. By integrating multi-level exposome data (geocoded structural
factors, individual social determinants, and perinatal exposures) with genomic and omic profiles, this study
will advance understanding of how environmental contexts interact with biological susceptibility to shape
ASD phenotypes, offering a foundation for tailored clinical management and novel preventive strategies.
While publicly available research datasets are critical to this effort, an integrated database on a well-
characterized, large, clinical population is essential. CHOP successfully implemented universal early autism
screening in its primary care network in 2011, and has studied early screening, diagnostic outcomes, and
prevalence through electronic health record (EHR) data since then. This cohort now includes 104,405
children born between 2008-2017 who were screened for autism at an 18- or 24-month well-child visit and
had at least one additional visit within the CHOP network at 4+ years of age. Thus, this is a well-
characterized and research-ready dataset of ~4000 children with autism and ~100,000 without. Our
proposed three-year project is to aggregate clinical and genomic data from CHOP’s EHR, clinical and
research biorepositories; with Penn’s EHR data on pregnancy, maternal, and birth outcomes, and research
databases (ROA Task 1). We will also generate geo-coded exposomic data including daily air and water
components, greenspace, built environment, and the Childhood Opportunity Index during pregnancy, birth,
and childhood (ROA Task 2). We will then use advanced data science methods to generate hypotheses
about relationships among and between variables to predict autism diagnosis and explain the increased
prevalence over time (ROA Task 3). With this resource and the predictive power of our machine learning
analytic plan, this project will have the statistical power to identify potential causes of autism in specific
populations (e.g., starting with genetic and phenotypic subgroups). We will develop a prediction model that
incorporates child-, family-, neighborhood- and community-level clinical, genomic, and exposomic data to
predict autism in our cohort of 104,405 children who were all screened for autism as toddlers and who are
now age 8-17 years. We will also identify genomic, exposomic, clinical-practice factors, and their
interactions, that contribute to the increase in autism prevalence and heterogeneity of the autism
phenotype, including increases in medical and genetic risks; changes in environmental exposures; and
critical changes in diagnostic practice, criteria, and service availability. Our multi-disciplinary team
represents the best clinical, informatics, genetics, data science, and community engagement expertise for
developing machine learning methods and tools for large-scale, high-resolution, meaningful, and actionable
autism research. If successfully implemented, this study will create an unprecedented data resource for
researchers to derive specific, testable causal hypotheses and definitively answer questions regarding
causes of autism in a way that was not previously possible. Furthermore, the results will parse the variance
across broad domains of genomic and exposomic factors that may cause autism, which is critical for setting
future research priorities.